High Throughput Screening to Discover Bacterial DNA Gyrase Poisoning Inhibitors

Antibiotic resistance poses a severe public health threat, causing 2.8 million infections and 35,000 deaths
annually in the US. The lack of new antibiotics in the past three decades raises urgent concerns about the
potential revival of deadly infections, emphasizing the necessity for new antibiotics development. This phase I
application aims to establish and develop an innovative high throughput screening (HTS) assay to identify
specific bacterial DNA gyrase inhibitors, poisoning inhibitors that stabilize the gyrase-DNA cleavage-complexes
and convert gyrase into a DNA damaging machinery. Bacterial DNA gyrase is a highly conserved and essential
enzyme found in all bacteria, but not in humans. It is an important and clinically validated target for discovering
and developing new antibiotics. Indeed, fluoroquinolones (FQs), a type of DNA gyrase poisoning inhibitors, are
among the most successful antibiotics targeting DNA gyrase. Unfortunately, bacterial resistance to FQs has
emerged. Under certain circumstances, FQs have serious side effects. Furthermore, since FQs have been
explored extensively, the potential limit of what FQs can achieve has likely been reached. Therefore, it is
necessary to develop compounds with novel chemical scaffold targeting DNA gyrase. One challenge is to rapidly
and efficiently identify gyrase poisoning inhibitors from thousands or millions of compounds in small molecule
libraries since HTS assays are not available for such efforts. In this application, we propose to establish a unique
HTS assay that can rapidly identify specific bacterial DNA gyrase poisoning inhibitors from small molecule
libraries. Specific aims are to 1) develop a unique high throughput screening assay to discover bacterial DNA
gyrase poisoning inhibitors; 2) utilize T5 exonuclease AT-hairpin- and/or supercoiling-dependent fluorescence
quenching (SDFQ)-based HTS assays to confirm the identification of novel gyrase poisoning inhibitors; and 3)
miniaturize and automate the HTS assay. Successful execution of the proposed research could lead to
commercializing a suite of three biochemical HTS assays to identify inhibitors for DNA topoisomerases including
gyrase and screening large compound libraries for gyrase poisoning inhibitors in future HTS campaigns, which
will be pursued in a subsequent phase II application.

Public health relevance
Antibiotic resistance is a critical threat to both US and global public health. The growing ineffectiveness of antibiotics in combating bacterial infections significantly undermines our capacity to treat common illnesses and could potentially lead to more untreatable medical conditions. The proposed research aims to create and develop a set of three high-throughput screening assays for commercial use, streamlining the discovery of novel antibiotics that poison bacterial DNA gyrase and address this pressing public health threat.